DRUG EFFECTS ON FUNCTIONS OF PHOSPHOPROTEIN B23

Protein B23 is a nucleolar phosphoprotein found in higher concentrations in tumor cells than in normal cells. This protein is associated with particles and is localized in the granular region of nucleoli where ribosomes are assembled. When treated with antitumor drugs (Actinomycin D., Luzopeptin or Toyocamycin), protein B23 is translocated from the nucleolus to the nucleoplasm. This result indicated that these antitumor drugs affect the protien B23 binding target in the nucleolus. The proposed experiments are designed to (1) identify the binding target of protien B23 in the nucleolus which is affected by the antitumor drugs and analyze this binding site's strucure (nucleotide and amino acid sequences) which will provide information for new drug development, (2) understand the function of protein B23 (its role in ribosome synthesis of tumor cells) and (3) establish a rapid and simple immunufluorescence method using the protein B23 antibody to screen antitumor drugs for their effect on inhibition of ribosome synthesis. Our long term goals are to understand the differences between the ribosome maturation processes in normal and cancer cells, to study the effects of antitumor drugs on ribosome synthesis and maturation, and to provide information for development of new inhibitors or competitors for ribosome synthesis which could be helpful in chemotherapy.